Administrative Core

PROJECT SUMMARY/ABSTRACT – ADMINISTRATION CORE
The University of Chicago Medicine Comprehensive Cancer Center (UCCCC) Administration serves as a
centralized unit responsible for coordinating, facilitating, and supporting basic, clinical, and population
sciences research, education and training, community outreach and engagement, cancer clinical trials, and
enhancing diversity, equity and inclusion. Administration supports 193 faculty members in 4 Research
Programs, and 10 Shared Resources with over $82M in cancer-relevant grants and 3,108 peer-reviewed
publications. Administration oversees ~300 active trials at any time and our interventional (treatment and
non-treatment) accruals grew from 5,786 to 6,644 (15% increase) during the grant period. Administration is
responsible for planning, operationalizing, and monitoring these activities. Administration provides
management and oversight of all activities that support the Director’s vision and the research of its members
including, but not limited to: strategic planning and monitoring; management of Center finances; personnel;
grants and contracts; purchasing; philanthropy; oversight of space utilization; facilitation of faculty
recruitment efforts; oversight of Shared Resources; Pilot Project and Team Science Award solicitation,
review, and funds allocation; improving clinical trials infrastructure; development of educational programs;
ensuring diversity, equity and inclusion; coordination of Center meetings and inter- and intra-programmatic
interactions; and communications with UCCCC members, the lay public, donors and other Cancer Centers.
Key accomplishments of Administration over the current grant period have included: development of a new
Strategic Plan; implementation of EVAL database to track membership, publications, and funding; revision
of and implementation of an enhanced cancer relevance policy; facilitation of key programmatic and
leadership recruits (45 new members from outside of the University of Chicago); development of team
science working groups and submission of multi-investigator grants such as SPOREs and P01s (4
submissions and 1 resubmission in the past two years); organization of a clinical trials task force which led
to significant reorganization and expansion of the infrastructure into the Clinical Trials Support Office;
facilitated development of the Accelerator for Cancer Therapeutics initiative between UCCCC and Argonne
National Laboratory; planned and launched two developing shared resources, Organoid and Primary Culture
Research Core and Cancer Metabolomics Platform; and established a new CCSG component, the Plan to
Enhance Diversity. Over the next grant period, Administration will build on these efforts to implement the
Strategic Plan and monitor its success; enhance the clinical trials infrastructure with continued investment
in new technology; continue to diversify our leadership via strategic recruitment; and enhance community
engaged research by developing a cancer health equity-focused center.